Hormone Therapy for Peri- and Postmenopausal Women with HIV (HoT)

As life expectancy increases with effective combination antiretroviral therapy (ART), more women with HIV
(WWH) are reaching menopause. WWH experience more frequent and severe vasomotor symptoms (VMS;
the collective term for hot flashes and night sweats) than women without HIV. The menopausal transition is
also associated with increasing risk of aging-related comorbidities such as osteoporosis/fracture,
cardiovascular disease and neurocognitive impairment that disproportionately affect WWH. Menopausal
hormone therapy (HT) is the most effective treatment for VMS; however, utilization is low and HT has never
been studied in WWH. We propose a randomized, double-blind, placebo-controlled, 2x2 cross-over trial (n=80)
to evaluate the efficacy of HT (transdermal estrogen plus oral progesterone) versus placebo for symptomatic
peri- and early post-menopausal WWH with VMS (Aim 1). We will also compare the effects of HT versus
placebo on neurocognitive function, mood, sleep and quality of life using a battery of assessments that have
been studied specifically in WWH during menopause (Aim 2). HT has noted anti-inflammatory properties;
therefore, we will evaluate the effect of HT on biomarkers of bone and cardiometabolic heath and examine the
role of systemic inflammation (Aim 3). Lastly, we will measure effects of HT on the HIV reservoir using the
Envelope Detection by Induced Transcription-based Sequencing (EDITS) assay, providing prospective
experimental data to validate observational data findings of increased inducible HIV reservoir in WWH after
menopause (Exploratory Aim). Our proposal leverages the resources and infrastructure of the AIDS Clinical
Trials Group (ACTG). Eligibility criteria and endpoints have also been designed to align with MsFLASH
(Menopause Strategies: Finding Lasting Answers for Symptoms and Health Trials) network trials to allow for
future analyses comparing HT response in women with and without HIV. The results of our study will provide
critical information about the role of HT in prevention of aging-related comorbidities and will elucidate whether
systemic inflammation is a modifiable mechanistic pathway. Further, this trial will set the groundwork for future
research comparing HT to non-hormonal therapies for treatment of VMS and prevention of comorbidities in
aging WWH.

Public health relevance
Project Narrative Women with HIV experience more frequent and severe menopause symptoms such as hot flashes and are at higher risk for the complications of reproductive aging such as neurocognitive impairment, bone loss, and heart disease. Hormone therapy can alleviate menopause symptoms but has not been studied in women with HIV. Using the infrastructure of the AIDS Clinical Trials Group, we propose to examine whether hormone therapy can effectively treat symptoms and minimize key aging-related comorbidities of menopause.